CRISPR Tiling

PROJECT SUMMARY- CORE 2
Fusion oncoproteins (FOs) enclose folded domains and intrinsically disordered regions (IDRs)
rearranged from fusion partner genes, contributing to condensate formation and oncogenic
transformation. Understanding of functional elements within FOs will elaborate on how FOs promote
aberrant gene expression and other types of chromatin deregulation in cellular cancer model systems.
The objective of Core 2 is to serve as a genetic platform for evaluating the FOs under study in Projects
1, 2, and 3. Based on the recently reported “CRISPR/Cas9 screening of protein domains”, Core 2 has
optimized a high-density CRISPR gene scan pipeline termed “CRISPR tiling.” This platform uses
libraries of sgRNAs to exhaustively and individually disrupt all 2-3 amino acid long regions within
proteins of interest, followed by testing for the contribution of the disrupted region to protein function.
The proposed CRISPR tiling strategy is innovative because it will provide a comprehensive and non-
biased evaluation of FO coding regions, thereby pinpointing critical elements within folded domains and
IDRs for FO-driven malignancies. The impact of Core 2 will be significant as it will assist with Projects
1, 2, and 3 in identifying novel mechanisms and therapeutic opportunities within the investigated FOs.

Public health relevance
PROJECT NARRATIVE- CORE 2 Fusion oncoproteins (FOs) enclose functional elements that drive oncogenic transformation. Core 2 will dissect the roles of folded domains and intrinsically disordered regions (IDRs) within FOs controlling malignant cell proliferation using the high-resolution CRISPR tiling strategy. The technology provided by Core 2 will directly support Projects 1, 2, and 3 and contribute to a broader understanding of how FOs control condensate formation and oncogenic programs in cancers.